CREATE (Center for Research, Education and Training Enhancement)

? DESCRIPTION (provided by applicant): This project brings together a long-standing need for Minority Serving Institutions to better fulfill their leading role in creating a strong and inclusie biomedical workforce. Florida A&M University currently trains Master's degrees in Molecular Cellular Biology, and Community Psychology as well as Doctorate degrees in Pharmacology, Public Health, Pharmacoepidemiology / Health Outcomes, Environmental Toxicology, Biomedical Engineering and Drug Delivery. Despite ranking among the top producers of black doctoral degree recipients in life sciences, our success in the contribution of independent investigators from biomedical and educationally underserved populations has been low. Increasing the quality of research education and the development of trainees in our research community is a top priority of the PI and our institution. This application maps our path forward to meet this challenge (in this application, biomedical refers to biological, behavioral, social, clinical, and environmental health sciences). We have identified a clear need for a new and innovative Center for Research Education and Training Excellence (CREATE) at Florida A&M University, and are seeking funding to establish this important resource. CREATE will serve intramural and extramural students and faculty who face potential barriers in their research careers, specifically addressing gaps in their self-preparedness and providing strategic lines of environmental support to foster a more productive research career among CREATE participants.

Public health relevance
PUBLIC HEALTH RELEVANCE The CREATE program is proposed on the philosophy that enhancing the quality of our graduates is dependent in part on a) cognitive and social dimensions of scientific reasoning and, b) continuing education and development of faculty mentors. The objectives and yearly activities of our CREATE community are designed to produce and create sustainable educational and health partnerships resulting in enhanced research and self-development abilities of student and faculty CREATE Scholars, particularly those from groups with known health disparities or disadvantaged backgrounds. It is our Vision that participants of our outcome-based program will have an enhanced capacity for research leadership in their chosen fields of biomedical, behavioral and clinical research.